HBV RNaseH inhibitors: Effects on HBV biology and resistance development

Hepatitis B virus (HBV) is a hepatotropic DNA virus that replicates by reverse transcription. It chronically infects
about 290 million people and kills ~900,000 annually. Therapy primarily employs nucleos(t)ide analogs that target
the viral DNA polymerase (P), but only a few percent of patients clear the virus so therapy is life-long. Reverse
transcription is catalyzed by coordinate action of the viral DNA polymerase (RT) that synthesized the DNA and
the ribonuclease H (RNaseH) that destroys the RNA after it has been copied into DNA. The RT and RNaseH
comprise adjacent domains of P, and the 2 enzymatic activities are allosteric and/or kinetically linked during
replication. Newly synthesized HBV genomes have 3 fates: to become nuclear covalently closed circular DNA
(cccDNA) molecules, be secreted within virions, or be integrated into the cellular genome. P is also a regulatory
protein that accumulates at the endoplasmic reticulum and helps suppress interferon responses.
The role of the RT in HBV replication is fairly well understood, but very little is known about how the RNaseH
contributes to HBV biology. We recently expressed recombinant HBV RNaseH suitable for mechanistic analyses
and drug discovery for the first time. We then developed the first screening pipeline for HBV RNaseH inhibitors
and identified >130 compounds that block HBV replication by inhibiting the RNaseH. The recombinant RNaseH
and inhibitors are unique new tools to probe contributions of the RNaseH to viral biology.
Premise: Our recombinant HBV RNaseH, RNaseH inhibitors, and RNaseH assays enable studies to reveal
how the RNaseH contributes to viral biology and how the enzyme can evolve resistance to RNaseH inhibitors.
Aim 1. What are the effects of inhibiting the RNaseH on HBV reverse transcription? We will evaluate how
RNaseH inhibitors affect RNA encapsidation, the fate of the RNA during reverse transcription when the RNaseH
is inhibited, reversibility of damage to the viral genome induced by RNaseH inhibitors, how blocking the RNaseH
affects cccDNA synthesis, and the specific infectivity of virions made without RNaseH activity.
Aim 2. What is the potential for resistance to RNaseH inhibitors? We will select resistance mutations to
RNaseH inhibitors in cell culture and then define their effects on viral fitness and selectivity against inhibitors
from 3 chemotypes.
Aim 3. How does inhibiting the RNaseH affect capsids and HBV’s interaction with cells? We will define
how RNA:DNA heteroduplexes generated by inhibiting the RNaseH affect HBV capsids, the effects of RNA:DNA
heteroduplexes induced by RNaseH inhibitors on interferon responses, and how heteroduplexes made without
RNaseH activity affect integration of HBV DNA into the host genome.
These data will define how the HBV RNaseH contributes to viral biology. This information will deepen our
understanding of HBV’s interaction with cells and provide essential context for our ongoing development of
RNaseH inhibitors as novel drugs intended to improve therapy for chronically infected patients.

Public health relevance
Hepatitis B virus (HBV) chronically infects ~290 million people world-wide and kills ~900,000 annually by inducing liver failure or liver cancer, but current therapies are not curative and only partially suppress disease progression. HBV replicates by coordinate action of the viral reverse transcriptase and ribonuclease H (RNaseH) activities, but the effects of the RNaseH on viral biology are very poorly understood despite the RNaseH being an attractive unexploited drug target. Here, we will use our unique recombinant HBV RNaseH, RNaseH assays, and inhibitors to define the RNaseH’s effects on viral replication, the spectrum of RNaseH resistance mutations that are selected by RNaseH inhibitors, and how the RNaseH affects HBV’s interactions with cells.